Phone Coaching as a Rescue Strategy for Early Non-Responders Enrolled in an Internet-Delivered Weight Loss Program

PROJECT SUMMARY
Effective, affordable, and scalable weight loss (WL) interventions are needed to reduce obesity prevalence
rates and improve obesity-related co-morbidities. Behavioral WL programs delivered via the Internet offer a
low-cost alternative to traditional face-to-face programs and have high dissemination potential, as the
intervention can be delivered entirely remotely. While these standardized Internet programs are effective for
many, a significant proportion of individuals still fail to achieve a clinically significant WL and may require a
more personalized treatment approach. One strategy for improving Internet-delivered WL (IDWL) treatment,
while still limiting delivery costs, is to use a stepped-care intervention approach, in which all individuals receive
a standardized Internet program and a more intensive intervention is reserved for those with suboptimal WL
outcomes. Previous research indicates that 4-week WL is strongly associated with long-term WL; thus 4 weeks
appears to be an opportune time to identify and provide early rescue efforts to initially non-responsive
individuals. Our research team has demonstrated that the provision of a brief period of individualized coaching
to early non-responders enrolled in IDWL treatment significantly improved intervention adherence and post-
treatment WL, when compared to early non-responders who received no coaching. The current study builds on
these findings and examines whether WL outcomes can be further improved through the use of extended
coaching, whether these effects are sustained once the phone coaching (PC) is removed, and whether these
interventions are effective from a cost perspective. 450 individuals will be randomized to: 1) IDWL+Brief PC for
early non-responders (`Brief'), 2) IDWL+Extended PC for early non-responders (`Extended'), or 3) IDWL only
(`Control'). All participants will receive an automated 4-month IDWL program and an 8-month IDWL
maintenance program. Early non-responders (4-wk WL <4%) randomized to `Brief' will receive 3 individual
phone calls, while those randomized to `Extended' will receive weekly phone calls throughout the WL program
(12 in total). Early non-responders randomized to `Control' will receive no PC. Assessments of weight, diet,
physical activity, and weight-related behaviors will be performed at baseline, 4, and 12 months. The primary
aim is to compare `Brief', `Extended' and `Control' on WL at 4 and 12 months. This study will also assess the
effect of moderators (sex, race/ethnicity, and early non-responder subgroup: 4-wk WL <2% vs. 2-4%) and
mediators (diet, physical activity, intervention adherence) on weight change, as well as the cost/kg of WL
across the 3 treatment arms. Findings from this study can be used to develop algorithms for choosing the
optimal amount of PC for early non-responders enrolled in an IDWL program. If effective, this program could
provide a low cost, yet personalized treatment approach for `at-risk' individuals receiving IDWL treatment.
Internet programs which incorporate PC for early non-responders could then be translated into healthcare and
community settings.

Public health relevance
PROJECT NARRATIVE Effective weight loss (WL) programs, which can be delivered remotely, have the potential to target and treat a larger percentage of the overweight and obese population, as they can be implemented within healthcare and community settings. While nearly half of all individuals enrolled in our automated, Internet-based, behavioral WL program can achieve a clinically significant WL, many do not achieve this WL threshold and may require additional support. Given previous research which suggests that these at-risk individuals may be able to be identified as early as one month into treatment, the proposed study examines whether the addition of brief (3 phone calls) or extended phone coaching (weekly phone calls) to early non-responders enrolled in an Internet- based WL program improves WL at 4 and 12 months and whether this is cost-effective.